The National Diversity in STEM Conference

Project Summary/Abstract
The biomedical and behaviorally-related sciences are faced with workforce challenges that must be considered
a priority if we are to meet the needs of the nation and drive health innovation. These challenges include lack of
diversity in the workforce, but more importantly, lack of access of Underrepresented Minorities (URM) to career
development programs that can allow them to enter the workforce. These challenges can be overcome, at least
in part, by establishing programs to disseminate vanguard scientific information, create diverse and inclusive
networks, and by establishing a system that promotes originality and allows creativity. The Society for the
Advancement of Chicanos/Hispanics and Native Americans in Science (SACNAS) is an inclusive, multi-
disciplinary and multicultural organization with a 45+ year history of interventions toward enhancing URM
participation in biomedical and behaviorally-related STEM (sciences, technology, engineering, and mathematics)
fields. As the largest minority serving scientific organization in the country, SACNAS aims to serve, educate,
promote, and prepare the next generation of successful URMs, particularly Hispanics and Native Americans, to
integrate them into the workforce and promote their advancement. The National Diversity in STEM Conference
has a long history of delivering high-quality programming. It provides a framework for the presentation of
innovative and original research, mentoring opportunities, trans-disciplinary panels, and professional
development workshops to URMs. Furthermore, the Conference will provide opportunities for discussions on
how we can best integrate and diversify biomedical and behavioral research, paying particular attention on how
to be inclusive of those most underserved and underrepresented. The three aims of this proposal are to: 1)
Support student participation at the Conference, 2) Support participation at the Conference of keynote
and session speakers conducting biomedical and behaviorally-related STEM research, and 3) Support
the development, organization and implementation of the Conference Programming. The ultimate goal of
the National Diversity in STEM Conference is to develop a well-prepared workforce, with a strong scientific
identity and self-efficacy through presentation of their own research, multiple encounters with mentors and
scientific speakers, role models, topic exerts, one-on-one mentoring settings, and purposeful professional
development advise at all levels of a biomedical career.

Public health relevance
Narrative SACNAS, the Society for Advancement of Chicanos/Hispanics and Native Americans in Science, is an inclusive, multi-disciplinary and multicultural organization with a 45+ year history of interventions toward enhancing Underrepresented Minority (URM) participation in STEM fields. The National Diversity in STEM Conference (Conference) aims at increasing preparedness of the scientific workforce by delivering a vanguard scientific program, provide a framework for research presentations, enable trans-disciplinary discussions, provide mentoring opportunities, and promote professional development of URMs in biomedically-focused and behaviorally-related STEM fields. The Conference will also encourage panel discussions on how we can best integrate and diversify biomedical research, paying particular attention to be inclusive of those most underserved and underrepresented (e.g. Native Americans).